International Society for Regenerative Biology Biennial Conference

PROJECT SUMMARY
This proposal requests partial funding for the second, third and fourth biennial conference of the
International Society for Regenerative Biology (ISRB) to occur over a five-year period, beginning with
ISRB’s second meeting scheduled for August 12-15, 2025 at the University of Wisconsin-Madison. The
inaugural meeting took place in Vienna September 2-6, 2023. More than 270 investigators, including
principal investigators, postdoctoral fellows, graduate and undergraduate researchers attended the
inaugural meeting. The ISRB was established in 2021 with an overarching goal to formalize an inclusive
and integrated community of scientists that study all aspects of tissue regeneration in invertebrate and
vertebrate model organisms. These include a dominant theme of basic discovery research, while also
welcoming engineering and regenerative medicine applications. ISRB membership has reached >300
individuals, with >150 faculty, >60 postdoctoral fellows, and >75 graduate students with more than half of
the current ISRB membership located in the United States. With continued meetings and activities, we
anticipate growing our membership. The society intends to provide highly international science experiences
for US (and all) trainees. In addition to organizing its own main conference, the ISRB also hosts virtual
events such as webinars, while supporting and enhancing other workshops and small meetings. ISRB will
convey the importance and impact of regeneration research to the greater scientific and lay communities,
highlight regenerative biologists and their discoveries, and promote regenerative biology by giving awards
for achievements and service, and by advocating for research and community funding.
The ISRB biennial conference is the premier opportunity for researchers in the broad field of tissue
regeneration across diverse species, tissues, contexts of injury, developmental stages and disease, to
meet and share data and ideas. A main goal of this meeting is to encourage interdisciplinary, cross-species
and cross-tissue comparisons as a key to enhancing understanding of the commonalities and divergences
in regenerative capacity and of the mechanisms regulating regeneration across paradigms – toward the
creation of an integrative framework. ISRB provides an interactive forum for students, postdoctoral fellows
and investigators at all stages to present their work and interact with other investigators, and the society
actively supports diversity and inclusion in science. In this proposal, financial support is requested to help
defray conference fees for attendees, with a goal of ensuring diversity among attendees and to enable
attendance of those at early career stages.

Public health relevance
As discussed in our Aims and proposal, an important focus of this conference is gearing talks and discussion from these talks towards ideas that lead to new treatments to stimulate endogenous regenerative responses to injury in disease in non-regenerative organisms. The conference organizers and session chairs (who serve as discussion leaders) will be seeking out and promoting ideas on how collaborative approaches can translate what is learned from highly regenerative organisms to less regenerative organisms, driving the long-term goal of discovering novel means of inducing regenerative healing responses in humans. INTERNATIONAL SOCIETY FOR REGENERATIVE BIOLOGY BIENNIAL CONFERENCE SAFETY PLAN The University of Wisconsin-Madison (UW-Madison) is committed to creating and maintaining a community dedicated to discovery, preservation and transmission of knowledge, wisdom and values that will help ensure the survival of this and future generations and improve the quality of life for all. In tandem, UW-Madison is resolute in providing a safe environment free of harassment, discrimination, or intimidation to all individuals who participate in activities on campus. To ensure all individuals on campus are aware of UW-Madison's commitment to creating a community free of harassment, discrimination, or intimidation, several policies and expectations of conduct are widely communicated through the UW Madison Policy on Sexual Harassment and Sexual Violence (“SHSV Policy”) and the UW System Policy on Discrimination, Harassment and Retaliation (“Nondiscrimination Policy”). The Nondiscrimination Policy prohibits discrimination and harassment on the basis of race, color, creed, religion, age, sex, sexual orientation, gender identity or expression, national origin, ancestry, disability, pregnancy, marital or parental status, genetic information, arrest record, conviction record, military service, veteran status, or any other category protected by law. The Nondiscrimination Policy also prohibits retaliation against an individual in response to, motivated by or in connection with an individual’s complaint or participation in an investigation of discrimination or discriminatory harassment. The SHSV Policy addresses sexual harassment, sexual assault, dating violence, domestic violence, stalking, sexual exploitation, and retaliation (“Prohibited Conduct”). The SHSV Policy outlines the University’s responsibilities and procedures related to Prohibited Conduct to ensure equitable and inclusive education, employment, and participation in an environment free of sexual violence and sexual harassment. Both policies apply to University faculty, staff, students (undergraduates, graduates, professional students), and third-party participants in any University programs and activities. Conference organizers and UW-Madison will respond promptly and effectively to any reports of harassment, discrimination, and Prohibited Conduct and will take the appropriate action to prevent, stop, and remedy conduct that violates the Nondiscrimination or SVSH Policies. Reporting Incidents of Harassment, Discrimination, or Prohibited Conduct • In the event a participant has a concern related to discrimination, harassment, sexual harassment, or sexual violence while attending an NIH-funded conference, that individual may report an incident to the conference organizers, the UW-Madison Office of Compliance Civil Rights Investigations (“OCCRI”) and/or the Sexual Misconduct Resource and Response Program (“SMRRP”). • If a conference attendee reports an incident to conference organizers, the conference organizers will immediately report the concern to OCCRI and/or SMRRP, the two campus offices responsible for receiving and investigating reports of discrimination, harassment, sexual harassment, or sexual violence. Consultation with these respective offices will determine the appropriate actions to be taken for those who are found in violation of the expectations of behavior. • Alternatively, a conference attendee can directly report an incident to OCCRI and/or SMRRP by submitting a webform through this link and navigating to the “Report an Incident” button under the respective unit. The complaint will be distributed to a member of the respective office the complaint was filed under, and contact will be made with the complainant according to UW-Madison policy. • If a conference attendee believes a crime may have occurred, a report should be submitted to the UWMadison Police Department (“UWPD”) for incidents occurring on campus, or to local law enforcement if the incident occurred off campus. UWPD can be reached at 608-264-2677 and the Madison Police Department (“MPD”) can be reached at 608-255-2345 for non-emergencies. For more information on how to file a report through the UWPD, please visit https://uwpd.wisc.edu/data-policies-resources/cleryact/report/. In an emergency, dial 911 for assistance. • In addition to reporting to conference organizers and/or OCCRI, SMRRP, UWPD, or MPD a conference attendee with questions, concerns, or complaints related to harassment and discrimination may also make a report to the Health and Human Services Office for Civil Rights (“HHS OCR”). To file a complaint online, visit the Office for Civil Rights Complaint Portal Assistant, send an email to [email], or call 1-800-368-1019; TDD: 1-800-537-7697. A complaint does not need to be filed with the conference organizers before filing a complaint of discrimination with the HHS OCR. Seeking assistance from the conference organizer does not prohibit those who have experienced discrimination from filing a complaint(s) with the HHS OCR. Individuals may also notify the National Institutes of Health (“NIH”) about any concerns of harassment, discrimination, and other forms of inappropriate behavior or conduct at NIHsupported events by accessing the NIH Find Help webpage and clicking the “Notify NIH” button at the bottom of the screen. Communication Strategy of Safety Plan to Conference Attendees The information contained within this safety plan is currently available to conference attendees through the conference website and will also be available in conference materials at the event. These materials are available digitally and in print form as part of the informational packet available to all attendees. At the time of the event, any allegations that arise from an incident at an NIH-funded conference or event will be documented and addressed in accordance with the procedures detailed in this plan. Allegations will also be shared with conference organizers as needed. The UW-Madison Title IX Coordinator, Lauren Hasselbacher, JD, or designee will be available to consult with conference organizers about specific concerns related to the event prior to and during the conference to ensure a safe, respectful environment for all participants. This conference location complies with section 504 of the Rehabilitation Act of 1973 and, as applicable, the Americans with Disabilities Act of 1990. Conference registration forms include a questionnaire for participants to voluntarily identify any special needs or accommodations needed to attend the conference. Organizers will review the requested accommodations and work with the relevant campus units to ensure these accommodations are available at the conference.